Using DNA Methylation Markers for Diagnosis and Prognosis of Upper Tract Urothelial Carcinoma

SUMMARY
Upper Tract Urothelial Carcinoma (UTUC) is a rare disease that accounts for 5-10% of all urothelial tumors
with an estimated annual incidence in Western countries of almost two cases per 100,000 inhabitants. The 5-
year specific survival is < 50% for stage 2-3 patients but < 10% for those with stage 4 disease. This poor survival
rate demands improvements in preoperative detection. Diagnosis and preoperative risk-stratification of UTUC
patients present distinct challenges given the limitations of current available tools. Although urine cytology has
an acceptable specificity to detect UTUC, the sensitivity is relatively low, particularly in low-grade carcinomas
and pelvicalyceal tumors. The invasive ureteroscopy (URS) biopsy can enhance the diagnostic accuracy, yet
under-grading and under-staging rates remain a concern at 32% and 46%, respectively. Nowadays, clinical
decision-making and the prognosis of UTUC relies heavily on TNM stage and pathological grade that is not
accurately available until radical nephroureterectomy (RNU) is performed. Major improvements in predictive tools
have occurred in recent years and unique parameters have been proposed to distinguish between low- and high-
risk tumors. DNA methylation alterations have emerged as potential diagnostic and prognostic factors for
urothelial carcinoma at the molecular level. For example, bladder cancer-specific DNA methylation changes can
be detected in urine sediments and can be used as non-invasive diagnostic or surveillance markers. Thus, a
personalized medicine approach for the diagnosis and prognosis of UTUC is urgently needed. The goal of this
study is to develop DNA methylation biomarkers to identify aggressiveness of UTUC. In a preliminary study, we
identified differential DNA methylation patterns in a small group of patients who had exhibited DNA markers for
UTUC aggressiveness. We hypothesize that bladder cancer DNA methylation marker panels can be used to: 1)
characterize UTUC-specific and/or aggressive UTUC specific DNA methylation markers in primary UTUC
specimens (Aim 1); 2) validate these markers in urine sediments of UTUC patients for monitoring disease
diagnosis, prognosis and recurrence (Aim 2). Results from this proposal will support further independent
investigations into the role of DNA methylation markers in UTUC diagnosis and prognosis, improve the standard
of care in predictive tools and different parameters have been proposed to distinguish between low- and high-
risk tumors and provide UTUC-specific DNA methylation profiles that aid physicians’ decisions.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health to develop assays for diagnosis, prognosis, and monitoring recurrence of patients with Upper Tract Urothelial Carcinoma (UTUC) in order to improve the overall survival benefit for these patients. There is urgent need for a novel personalized medicine approach, and this can be achieved by identifying and validating new DNA methylation biomarkers to identify a priori which patients will have favorable outcomes prior to any treatment taking place or monitor treatment responseand possible disease recurrence. The success of this proposal will minimize unnecessary chemotherapy administration for patients before surgery, reduce the associated patient morbidity/mortality, reduce delays to surgery, improve patient quality of life and reduce the overall health burden that is associated with receiving unnecessary chemotherapy. The mission of this proposal is to improve the overall clinical management for UTUC patients.